Alveolar macrophage and epithelial cell lipid metabolism in pulmonary fibrosis

PROJECT SUMMARY
Richard Watson, MD, PhD, is a Clinical Instructor of Medicine in the Division of Pulmonary and Critical Care
Medicine at the University of California, Los Angeles (UCLA). His clinical and research interest is in idiopathic
pulmonary fibrosis (IPF), a disease that results in the progressive, irreversible scarring of the lung and has no
curative treatment. A five-year research career development plan is proposed, focused on determining the
mechanisms of lipid metabolism in IPF, which will serve to establish Dr. Watson’s independent translational
research program. This proposal builds upon his strong basic science background and provides new training in
epithelial biology, next-generation sequencing techniques, bioinformatics, and translational research utilizing
human patient samples. During the award term, Dr. Watson will be mentored by Dr. Steven Bensinger, a leader
in the field of immunometabolism and lipid biology with a track record of mentoring over 15 graduate students,
post-doctoral fellows, and junior faculty to independent careers in biomedical research. He will have additional
support from co-mentor Dr. Steven Dubinett, a world-renowned lung cancer immunologist, and a strong team of
advisors with diverse but complementary areas of expertise.
During his post-doctoral training, Dr. Watson established an innovative research platform that leverages
advanced mass spectrometry-based techniques with a series of loss-of-function genetic murine models. Using
this unique system, Dr. Watson has begun to mechanistically dissect the intricate, lipid-rich metabolic circuit
represented by the distal airway. Dr. Watson has demonstrated that the lipid metabolic state, or lipidome, of the
alveolar macrophage (AM) is dramatically reprogrammed during IPF pathogenesis. This is characterized by the
generation of monounsaturated fatty acids (MUFAs) through the upregulation of the lipogenic enzyme stearoyl-
CoA desaturase (SCD), which serves as a protective factor against pulmonary fibrosis. In this proposal, Dr.
Watson aims to study the complex metabolic relationship between AMs and alveolar epithelial type II cells
(AT2s). Aims 1.1 & 1.2 build upon preliminary in vitro data indicating that SCD functions through cREL and
NFκB to modulate proinflammatory signaling and seek to determine how changes in macrophage lipid
composition relay information to the cell’s epigenome and transcriptome. Aim 1.3 utilizes human IPF
biospecimens and multiplex immunofluorescence technology to determine the spatiotemporal regulation of
macrophage SCD in IPF pathogenesis. Aim 2.1 of the proposal leverages a novel in vitro co-culture organoid
system that can recapitulate much of the complexity of the alveolar space, allowing rapid screening of small-
molecule inhibitors that may have therapeutic potential for treating IPF. Aims 2.2 & 2.3 will utilize a series of
lineage-specific genetic murine models to mechanistically dissect the fatty acid biosynthetic pathway in AMs and
AT2s and their symbiotic relationship in the airway. Completion of these aims will mechanistically advance our
understanding of the lipid metabolic circuitry of AMs and AT2s in IPF.

Public health relevance
PROJECTIVE NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a complex disease that results in progressive, irreversible scarring of the lung, for which there is currently no curative treatment available. There is a critical need for novel therapeutic strategies to combat IPF; however, this first requires a deeper mechanistic understanding of this deadly disease. Our project will determine the role of lipid metabolism in alveolar macrophages and epithelial cells, and how these cell types function together to modulate profibrotic signaling in IPF, advancing our understanding of the disease and facilitating the development of novel therapies.